Role of Metabolic Reprogramming in Formation and Maintenance of the Acta2+ Atherosclerotic Lesion Protective Fibrous Cap

Atherothrombosis, resulting from rupture or erosion of unstable atherosclerotic plaques, is the leading cause of
death worldwide. However, the mechanisms that regulate the stability of late stage atherosclerotic lesions remain
poorly understood. Recent studies from our lab showed that smooth muscle cell (SMC) conditional knockout of the
platelet-derived growth factor receptor-β (PdgfrbSMC-Δ/Δ) in ApoE-/- mice was associated with nearly complete failure
of SMC to invest into lesions or the fibrous cap. However, surprisingly we observed no changes in lesion size or
indices of plaque stability, including the thickness of the Acta2+ fibrous cap, following 18 weeks of Western diet (WD)
feeding. Further investigation provided novel insights regarding the mechanisms underlying these changes. Key
findings included: 1) contrary to long-standing dogma that Acta2+ fibrous cap cells are derived almost exclusively
from SMC, we showed that they account for only 60-70% of Acta2+ cells in advanced ApoE-/- brachiocephalic (BCA)
or human coronary artery lesions with the remainder coming from endothelial cell-to-mesenchymal-to-myofibroblast
transitions (EndoMT-MFT, 20-25%) and macrophage-to-myofibroblast transitions (MMFT), 10-15%) respectively; 2)
loss of SMC investment into lesions with SMC PDGFRB KO was associated with large adaptive increases in
EndoMT-MFT and MMFT; 3) increased EndoMT-MFT, and MMFT did not sustain indices of stability when WD
feeding was extended to 26 weeks suggesting there may be qualitative differences in Acta2+ fibrous cap cells
depending on their origin; 4) RNA-seq analysis on the BCA of 18-week WD-fed PdgfrbSMC-Δ/Δ ApoE-/- mice versus
control littermate mice showed that energy metabolism pathways were the top ten upregulated pathways suggesting
that metabolic reprogramming may be required for SMC-MF, EndoMT-MF, and MMF transitions; and 5) inhibition of
aerobic glycolysis in cultured SMC prevented their transition to a MF state following treatment with PDGF and TGFβ.
Studies in this proposal will test the hypothesis that SMC, EC, and macrophage adaptive responses for maintaining
plaque stability require major shifts in energy metabolism and that the metabolic state of these cells can be
manipulated to stimulate beneficial changes in the phenotype of lesion cells and overall increases in plaque stability.
Aim 1 will determine if genetic knockout or pharmacologic inhibition of aerobic glycolysis in SMC and EC lineage
tracing ApoE-/- mice with advanced atherosclerosis is associated with evidence of reduced plaque stability. Aim 2 will
determine if genetic or pharmacologic promotion of aerobic glycolysis in SMC and EC lineage tracing ApoE-/- lineage
tracing mice with advanced atherosclerosis is associated with increased plaque stability. Studies for both aims will
include human validation studies using scRNAseq and histological data from stable asymptomatic versus unstable
symptomatic carotid endarterectomy samples. All studies will assess sex-dependent determinants of late-stage lesion
pathogenesis. Taken together, the proposed studies will provide novel insights regarding mechanisms by which
metabolic reprogramming of cells contribute to the cellular and extracellular matrix (ECM) composition of the fibrous
cap and may lead to development of novel pharmacological and dietary approaches for enhancing plaque stability.

Public health relevance
Project Narrative/Relevance: Atherosclerosis is a progressive chronic inflammatory disease that remains the leading cause of death in the USA and worldwide in spite of widespread use of statins, other lipid lowering strategies, and life-style modifications. Remarkably, despite decades of research, little is known about late stage lesion development and mechanisms that result in the rupture or erosion of the protective fibrous cap overlying advanced atherosclerotic lesions leading to catastrophic thrombotic events including a heart attack (i.e. myocardial infarction) or stroke. The goal of studies in this proposal is to develop novel approaches for reducing the late stage clinical complications of atherosclerosis through dietary and/or pharmacological approaches that induce metabolic reprogramming of the key cell types that we have recently shown form the protective fibrous cap, enabling them to form a thicker and mechanically more robust fibrous cap (i.e. analogous to a stronger patch on a tire), and thereby reducing the probability of lesion rupture or erosion leading to a possible heart attack or stroke.